Sialylation of TLR2 Induces Osteoclast Fusion and Th 17 differentiation During Aging

Abstract
Aging of skeleton becomes more susceptible to develop autoimmune disease such as rheumatoid arthritis (RA).
Increased osteoclast activity and bone resorption is partly responsible for deterioration of skeleton during aging.
We have shown that aberrant activation of osteoclast formation in the subchondral bone initiates uncoupled
remodeling activity to induce degeneration of joints in both RA and osteoarthritis (OA). The elevated osteoclast
activity in the subchondral bone is also responsible for the joint pain. However, the signaling mechanism of
increased osteoclast fusion and bone resorption is unclear in RA. Interestingly, sialic acid level in serum and
sialylation of cellular receptors continuously increase during with implication of skeleton aging and autoimmune
disease. We found that sialylation of TLR2 induced binding to Siglec15 to initiate osteoclast fusion for bone loss.
Trap+ mononuclear cells with RANKL undergo cell-cell fusion to form Trap+ multinuclear osteoclasts. The
mechanism of RANKL-induced osteoclast fusion and maturation are not fully understood. Our preliminary results
showed that RANKL induced transcription of α2,3-sialyltransferase ST3Gal1 in preosteoclasts. Noteworthy, the
sialylation of TLR2 by ST3Gal1 induces binding to Siglec15, a member of sialic acid-binding lectins of the
immunoglobulin superfamily, to promote osteoclast fusion for bone resorption.
In parallel, our preliminary results also showed that the binding of sialylated TLR2 to Siglec 15 induced biased
Th17 differentiation of CD4+ T cells at onset of RA development. We now know that Th17 T cells are involved in
nearly all major autoimmune diseases, including RA, multiple sclerosis (MS), inflammatory bowel disease (IBD)
and systemic lupus erythematosus (SLE). It is critical to understand the divergent functions of Th17 cells in
homeostatic and disease states. Th17 cells also promote the maturation of B cells for autoimmune antibody
generation. Most importantly, our preliminary results showed that soyasaponin Bb, a triterpenoid saponin from
soy, effectively inhibited α2,3-sialyltransferases activity in both aged and RA mice. Thus, we hypothesize that
sialylation TLR2-induced osteoclast fusion and biased Th17 differentiation of CD4+ T cells during aging
accelerates skeleton deterioration susceptible to development of autoimmune disease such as RA. In
the proposed study, we will first characterize mechanism of sialylated TLR2-induced osteoclast fusion in Specific
Aim 1. We will then investigate the effect of sialylation of TLR2 on T cells at onset of RA. We will finally examine
the therapeutic effect of Soyasaponin Bb sialyltransferase inhibitor on RA. Inhibition of TLR2 sialylation by
soyasaponin Bb could mitigate age-induced biased differentiation of Th17 and osteoclast fusion.

Public health relevance
Project Narrative During aging, skeleton undergoes deterioration and becomes more susceptible for development autoimmune disease including rheumatoid arthritis. Sialic acid level in serum and sialylation of cellular receptors continuously increase during aging implicates pathogenesis of skeleton aging and autoimmune disease. The objective of the proposed study is to develop a therapeutic treatment using a sialylation inhibitor Soyasaponin Bb for rheumatoid arthritis.